Neural signals controlling generalized deficits in motivation

Generalized deficits in motivation and impaired reward-seeking are behavioral symptoms associated
with mental health disorders. Identifying the neural signals responsible for generalized deficits in motivation
requires a task capable of examining the motivation to work for multiple reward options. While common
motivation assays can track a reduction in effort when a reward is decreased in size, these assays typically
offer a single reward option and cannot be used to study generalized deficits in motivation in a single setting.
To overcome this limitation, the lab developed a novel rodent task that simultaneously assesses the motivation
to work for two distinct rewards. In this task the effort required to earn a reward increases across trials under a
progressive ratio (PR) reinforcement schedule (Concurrent PR task). Importantly, the PR schedules for both
reward options are independent of one another. Rats were exposed to test sessions where one of the reward
options was decreased in size. Rats were categorized based on their reward seeking strategy during tests
sessions to examine how the net yield of rewards is impacted by changes in motivation. Reward ‘maximizers’
earned the same/more rewards than would be expected whereas reward ‘non-maximizers’ earned fewer
rewards than would be expected. Preliminary data illustrate that ‘non-maximizers’ decrease the motivation to
work for both reward options. The goal of this proposal is to (1) identify the neural signals responsible for
generalized motivational deficits in rats employing a ‘non-maximizer’ strategy and (2) implement rational
strategies to reverse these motivation impairments.
Altered dopamine signaling in the nucleus accumbens core (NAc) could mediate these generalized deficits
in motivation since NAc dopamine facilities high-effort actions and contributes to value-based decision-making.
In preliminary studies we recorded NAc dopamine in rats trained on the Concurrent PR task. During test
sessions when one reward was decreased in size, ‘non-maximizers’ exhibited smaller dopamine responses to
both reward options relative to ‘maximizers’. The phenomenon could be explained by (1) the dopamine system
in ‘non-maximizers’ reflecting changes in the average reward size at a faster rate relative to ‘maximizers’ or (2)
‘non-maximizers’ having an intrinsically smaller reward-evoked dopamine response relative to ‘maximizers’. In
this proposal, NAc dopamine release will be recorded to determine which model (difference in updating reward
value vs intrinsic difference) accounts for the dampened reward-evoked dopamine response in ‘non-
maximizers’ (Aim 1). These findings will inform the predictions in Aim 2, where optogenetic manipulations of
reward-evoked dopamine release will be performed to identify rational strategies to reverse generalized deficits
in motivation.

Public health relevance
Narrative A generalized deficit in motivation is a behavioral symptom associated with mental health disorders. However, standard assays of motivation are not capable of tracking deficits in motivation across multiple reward options in a single setting. This proposal will use a novel assay of motivation to identify the neural signals responsible for generalized motivational deficits and to implement rational strategies to reverse these motivation impairments.